Development and Preliminary Validation of a Bleeding Quality of Life PatientReported Outcome Measure for Older Adults

PROJECT SUMMARY/ABSTRACT
Anticoagulation can prevent thrombosis but at the expense of increased risk of bleeding, and older age is
associated with increasing risk of both thrombosis and bleeding. Older adults may be particularly vulnerable to
the effects of bleeding due to the co-occurrence of risk factors like multimorbidity, disability, cognitive
impairment, falls and polypharmacy. Established definitions of bleeding outcomes focus on quantification and
healthcare utilization. They do not capture smaller volume bleeding that commonly affects older adults, nor do
they assess the effect of anticoagulant-related bleeding on function, independence and other outcomes
important to older adults. We lack a measure of anticoagulant-related bleeding in older adults that accurately
reflects their experience, which in turn limits our ability to improve patient-centered outcomes. The objective of
this proposal is to establish a novel patient-reported outcome measure for bleeding-related QoL for older adults
taking anticoagulants. Using a cohort of older adults with atrial fibrillation or venous thromboembolism taking
anticoagulants, we will pursue two aims: 1) to develop a patient-reported bleeding QoL questionnaire for older
adults taking anticoagulants, and 2) to perform preliminary validation of a patient-reported bleeding QoL
questionnaire for older adults taking anticoagulants. This proposal will have a significant impact by generating
an outcome measure that better reflects patients’ experiences, goals and values, which can be incorporated
into clinical trials and other research, clinical care, and public health and health systems interventions. This
work will lead to future projects including prospective measurement of changes in QoL over time and its impact
on anticoagulation decision-making, as well as design of targeted interventions to improve QoL for older adults
with bleeding.

Public health relevance
PROJECT NARRATIVE This proposal promotes public health because it creates a novel patient-reported measure of the effect of anticoagulant-related bleeding on quality of life in older adults. A comprehensive measure will generate knowledge on the experience of older adults taking anticoagulants and can be incorporated into observational studies, clinical trials, population health interventions, and quality improvement initiatives to improve outcomes for older adults with thrombosis. The project is consistent with the National Institute on Aging’s mission to develop and advance knowledge to improve the prevention, diagnosis, and treatment of common diseases and conditions of aging in vulnerable patient populations.